Colorado Undergraduate Research in Environmental Health Sciences

Abstract
This project proposes to continue our highly successful research and mentorship program for undergraduate
students to enhance diversity in the environmental health sciences (EHS) based at the University of Colorado
Anschutz Medical Campus. Our program, the Colorado Undergraduate Research in Environmental Health
Sciences (CUrehs), will draw students from the University of Colorado downtown Denver campus which has a
large underrepresented population of students. Our program intends to expose students to research experiences
and mentorship in EHS for one year and will include an intensive summer program that trains them in the
responsible conduct of research, and provides them with the confidence and guidance to pursue graduate
education. Overall, our CUrehs program provides an integrated 3-pronged approach to developing student
interest in environmental health sciences research and careers: (1) Laboratory Experience; (2)
Social/Community Development; (3) Educational/Field Trip Experiences. We have trained a total of 43 students
during the past funding cycle with success as measured by students applying to professional or graduate school,
publications and presentations at local and national conferences. Our goal remains to enhance diversity in the
environmental health sciences by meeting the following aims:
1. Advance our successful research-training program for undergraduate students in the environmental
health sciences.
2. Strengthen the undergraduate studies in EHS at the University of Colorado while improving the
participants' preparedness for graduate or professional school.
3. Enhance the diversity of students progressing to graduate or professional school in environmental health
sciences.

Public health relevance
Narrative This training program recruits 6 undergraduate diversity students for research experiences and mentorship in environmental health sciences for one year and will include an intensive summer program focusing on laboratory experiences, mentoring, responsible conduct of research training and educational/inspirational experiences. Students will gain a better understanding of future career options and how to prepare for graduate or professional school with a long-range goal of increasing the number and quality of diversity students pursuing a career path in basic, translational or clinical environmental health sciences research.